Exploiting Diversity-Oriented Chemical Synthesis for Combating Chronic Parasitic Infection

PROJECT ABSTRACT
Toxoplasma gondii is a widespread parasite of animals that causes opportunistic infections in humans.
Although healthy humans control the infection, they are not able to completely eliminate the bradyzoite stage
that reside in neurons and muscle cells. Hence, they remain chronically infected. Complications occur due to
reactivation of chronic infections in immunocompromised patients. Complications also can arise from new
infections during pregnancy when the parasite can cross the placental barrier and infect the developing fetus. It
is estimated that ~ 2 billion people worldwide are chronically infected with T. gondii and hence at risk of
reactivation should their immune functions decline. Existing chemotherapy for T. gondii is only effective at
suppressing acute infection due to the tachyzoite stage but it is unable to eradicate the chronic bradyzoite
stage. The goal of this project is to identify preclinical drug candidates that show potent inhibition of parasite
growth including elimination of bradyzoites. Preclinical candidates will be identified based on efficacy against
chronic toxoplasmosis in vivo and appropriate metabolism and safety profiles for advancement to the clinic. We
will focus on the highly promising bicyclic pyrrolidine scaffold that targets phenylalanine tRNA synthetase
(PheRS) to develop inhibitors that are both potent and selective. We will design, synthesize, and test new
analogs to develop structure activity relationships for on-target activity. We will optimize potency, selectivity,
brain penetration, bioavailability, metabolism and pharmacokinetic (PK) properties of lead compounds. Specific
go no/go criteria for potency, selectivity and PK properties will be used to advance compounds to in vivo
testing. Genetic and genomic approaches will be used to identify potential resistance mechanism, and to
address the mechanisms of action of leads. We will employ quantitative assays for monitoring inhibition of
bradyzoite growth in vitro, and animal models for monitoring the efficacy of lead compounds against
reactivated toxoplasmosis in the brain. Successful achievement of these goals will deliver preclinical
candidate(s) for future IND-enabling studies with the eventual goal of curing chronic toxoplasmosis.

Public health relevance
PROJECT NARRATIVE Up to 2 billion people worldwide are chronically infected with T. gondii, and many may harbor tissue cysts in their organs and tissues. Infected humans have high risk of reactivation should their immune system decline. Existing drugs suffer from toxicity, allergic reactions and fail to eliminate chronic infection. The proposed research will identify new drug candidates for eradicating chronic infection, including within the central nervous system.